Natural language processing and medical imaging analysis for multi-modality computer assisted diagnosis of ophthalmic diseases

PROJECT ABSTRACT
No change since original proposal

Public health relevance
PROJECT NARRATIVE No change since original proposal